MULTICENTER, RANDOMIZED STUDY OF IRBESARTAN IN HEART FAILURE TREATMENT

Project objective is to determine whether Irbesartan will induce dose-related decreases in PCWP following 12 weeks of once-daily therapy in subjects with heart failure.